Circulating Proteomics to Phenotype the Development and Reversal of Myocardial Remodeling in Aortic Stenosis

ABSTRACT: Aortic stenosis (AS) carries significant morbidity and mortality and is a highly prevalent heart
valve disease of aging (5-10% of those ³65 years). While treatment with aortic valve replacement (AVR) has
historically been reserved for symptomatic severe AS, irreversible myocardial remodeling/injury occurs prior to
the onset of symptoms, before AS is “severe”, and contributes to death and persistent heart failure (HF) in up
to 40% of patients 1 year after AVR. To reduce the morbidity and mortality of AS, there is an invigorated focus
on early-stage AS with goals of (1) advancing medical therapy to slow disease progression; and (2) earlier
timing of AVR before symptoms and before AS is severe. A major roadblock for operationalizing this paradigm
is detecting early-stage pre-symptomatic AS. While an echocardiogram (echo) is the gold standard for AS
diagnosis, physical exam (auscultation) and patient history (e.g., dyspnea, chest pain) are the gatekeepers to
trigger an echo order, but they are insensitive (missing AS), non-specific (leading to needless echoes), and
biased to detect late-stage AS. Universal echo screening for AS would be exceedingly expensive, wasteful,
strain capacity, and difficult to disseminate broadly. A widely available and accessible pre-screening strategy—
with high sensitivity/specificity—to increase the detection of early-stage AS and efficiently deploy echo in the
diagnosis of AS represents a critical unmet need to optimize outcomes for AS. Accordingly, our long-term goal
is to develop, validate, and implement a blood-based multi-marker screening test for the detection of AS
among those ³65 years of age. Other (pre)screening strategies have substantial real-world implementation
barriers, but a blood test is a novel approach to detect AS that would enable widespread deployment in diverse
populations and improve the efficiency of echo in AS diagnosis. The central hypothesis of this application is
that valve stenosis and myocardial remodeling/dysfunction resulting from pressure overload will be
accompanied by alterations in the circulating proteome useful for detecting individuals with AS. To build on our
promising pilot data, we propose to discover and prioritize proteins for a multi-marker panel to detect
individuals with AS. Existing plasma samples from two discovery cohorts—each with individuals with AS and
age/sex/race-matched controls without AS (presence/absence of AS verified by cardiac imaging)—will be used
for high-dimensional proteomics. Several statistical approaches, including machine learning, will be utilized to
discover a smaller set of known/novel proteins most strongly associated with AS in logistic regression. The
proposed project is closely aligned with encouraged avenues of research outlined in the NOSI (NOT-HL-23-
078) and CAROL Act. Completion of the proposed aim in this administrative supplement will pave the way for
the development and validation of a custom multiplex panel for the detection of AS.

Public health relevance
NARRATIVE To reduce the morbidity and mortality of aortic stenosis (AS), there is an invigorated focus on early-stage AS with goals of (1) advancing medical therapy to slow disease progression; and (2) earlier timing of aortic valve replacement (AVR) before symptoms and before AS is severe. A major roadblock for operationalizing this paradigm is detecting early-stage pre-symptomatic AS. Our proposed analyses will pave the way for the development and validation of a custom multi-protein blood test for the detection of AS, which is anticipated to (1) reduce morbidity and mortality from AS as patients are treated with AVR earlier; (2) facilitate patient enrollment in medical therapy trials aiming to slow disease progression; and (3) use of a blood test to complement and increase the specificity of auscultation will decrease the number of unnecessary echoes performed to “evaluate murmur”, thereby saving costs.